Addressing biological and therapeutic gaps in rare neuroendocrine cancer with a novel organoid-based model

Abstract
The work proposed on the parental grant is focused on developing new organoid models of rare and
understudied neuroendocrine tumors pheochromocytomas and paragangliomas to improve our understanding
of their biology and serve as a drug screen platform. Mutations in genes of the hypoxia pathway are a feature of
approximately 40% of pheochromocytomas and paragangliomas and involve most metastatic forms of these
tumors. In this diversity supplement we propose to extend the parent grant by testing the effects of hypoxia in
the fitness and molecular features of the organoid cultures. We will also investigate whether hypoxia alters the
organoids’ drug response profile. These findings will improve our knowledge of factors that influence organoid
properties and may offer insights into drug sensitive/resistance patterns that might impact on future therapeutic
testing.

Public health relevance
Narrative To address “PQ9: What methods can be developed to effectively study small or rare populations relevant to cancer research” we will develop organoids of rare neuroendocrine tumors pheochromocytomas and paragangliomas (PPGL). Here we will include a critical control for these cultures- we will test whether culturing the organoids under different levels of hypoxia impact the fitness of the culture and the response to drugs. These results will offer new insights to identify potential biomarkers and new therapies.